Development and Feasibility of a Behavioral Activation Intervention to Support Independence in Older Veterans at Risk for Functional Decline

Background: Half of all Veterans are aged 65 or older. Age and associated chronic conditions increase risk
for functional limitations, defined as difficulty performing day-to-day activities. This is significant not only
because older Veterans place a high priority on maintaining function, but also because the manifestation of
limitations signifies elevated risk for adverse outcomes. Effective interventions are needed to help older
Veterans maintain independence in the community. This project will adapt an empirically-supported
psychosocial therapy for depression – behavioral activation (BA) – to promote physical, cognitive, and social
functioning in community-dwelling older Veterans at risk for functional decline. As a brief intervention that
increases engagement in values-aligned activities, BA is a promising approach to support functioning.
Specific Aims and Methods: We will develop and pilot test a six-week telehealth-delivered BA intervention,
“Behavioral Activation for Independence in Older Veterans” (ACTIVaTE). The intervention will be designed to
increase engagement in meaningful activities in line with individual values. The target population is older
Veterans (age ≥65) enrolled in VA primary care who are at risk for functional decline, defined as a score of ≥3
on the Vulnerable Elders Survey (VES-13). This will be accomplished over three aims:
Aim 1. Adapt: We will develop ACTIVaTE based on an existing BA model (Brief Behavioral Activation
Treatment for Depression-Revised) for delivery to older Veterans at risk for functional decline via VA Video
Connect (VVC). Our previous experience with BA will inform the initial adaptation, incorporating perspectives
from primary care, geropsychology, and occupational therapy. We will seek feedback on the preliminary
manual and participant workbook via semi-structured interviews with VA psychologists (n=5), occupational
therapists (n=5), and Veterans (n=5), using findings to further modify the materials.
Aim 2. Refine: We will conduct an open trial of ACTIVaTE delivered via VVC in 10 older Veterans at risk for
functional decline, using mixed methods to determine preliminary acceptability of the intervention. Further
refinements will be made to the intervention based on findings from qualitative interviews and a satisfaction
survey using the Theoretical Framework of Acceptability.
Aim 3. Test: We will conduct a pilot RCT of ACTIVaTE versus attention control in 48 older Veterans with VES-
13 score ≥3 recruited from primary care. We will collect clinical measures at baseline, 6 weeks, and 12 weeks,
using the Ambulatory Measure for Post-Acute Care (AM-PAC) and PROMIS Satisfaction with Social Roles and
Activities as primary measures of physical, cognitive, and social functioning. We will also conduct semi-
structured interviews with a purposive sample of participants based on satisfaction and adherence. Feasibility
will be determined by enrollment and retention and acceptability will be determined by adherence and
satisfaction, as well as by themes from qualitative interviews. Preliminary impact on AM-PAC and PROMIS will
be explored through within and between groups mixed-effects linear regression models and proportions of
participants who achieve minimal clinically important change in outcomes.
Impact: This project will adapt an evidence-based intervention for depression (BA) for a novel purpose:
promoting functional independence in older Veterans. Through VVC delivery, it has potential for scalability and
implications for isolated and rural Veterans. Data will be used to inform the design of a future full-scale efficacy
trial (RR&D Merit Award). In parallel with my research aims, I will obtain training in behavioral and rehabilitation
science, methodology (clinical trials design and analytic techniques), grant writing and scholarly dissemination,
and leadership. While supporting the development of an innovative, values-aligned treatment targeting
functioning, this CDA-2 will also promote my growth into an independently-funded VA physician investigator
innovating at the interface of primary care, behavioral health, and rehabilitation.

Public health relevance
As Veterans age, chronic health conditions increase their risk of functional limitations, or difficulty completing day-to-day activities independently. Older adults with functional limitations are more likely to be hospitalized or admitted to long-term care facilities. Maintaining independence at home and in the community is a high priority for many older Veterans. However, there are few existing interventions focused on helping older Veterans maintain their independence, and they rarely target multiple areas of functioning (e.g. physical, cognitive, and social). The goal of this CDA-2 proposal is to support the physical, cognitive, and social functioning of older Veterans by developing a program based on behavioral activation, an evidence-based brief psychosocial intervention that helps individuals increase their engagement in activities aligned with their values (i.e. what matters most to them). This project will simultaneously support the career development of the candidate into an independent VA researcher focused on promoting functional independence in older Veterans.